PERCEPTION OF VARIABILITY WITHIN AND BETWEEN GROUPS

Nine experiments are proposed to further our understanding of the perception of variability between and within social groups. One line of investigation explores the role of visual cues. Experiments 1-3 are designed to demonstrate that the perception of similarity in appearance within groups and of differences across groups may be sufficient to produce the basic facts of intergroup relations: categorization, stereotyping, prejudice, and discrimination. The procedures will involve the creation of arbitrary physical similarities and differences among persons. Experiments 4 and 5 examine the role of visual cues and attributional processes as determinants of whether stereotypes about a group influence the perception of an individual group member. The second line of investigation examines the "psychophysics" of between-group differences. Experiments 6 through 8 explores the causes and consequences of the perception of minority groups as being more criminal than nonminority groups. It is suggested that a small absolute difference between groups in crime rate appear large when the absolute percentages involved are small. Exposing people to the percentages of group members who are "law- abiding" would make minority and nonminority groups appear more similar in criminality. Experiments 9 extends these ideas to the perception of research results, and other applications are suggested as well. All 9 experiments directly bear on the serious social problem of intergroup antagonism, especially the interracial conflicts manifested in the difficulty of achieving integration in housing and education.